Roles of p53-Regulated Pro-Survival Signals in Carcinogenesis by HTLV-1 and High-Risk Subtype HPVs

The human T-cell leukemia virus type-1 (HTLV-1) is a delta oncoretrovirus that infects and transforms
CD4+ T-cells and causes adult T-cell leukemia/lymphoma (ATLL), an aggressive hematological
malignancy that is generally resistant to conventional anticancer therapies. The 3' end of the HTLV-1
genome encodes several regulatory proteins (i.e., Tax, Rex, HBZ, p8I, p12I, p13II, and p30II) from a highly-
conserved nucleotide sequence, known as pX, which is retained in the majority of ATLL clinical isolates.
For nearly four decades, the HTLV-1 has been extensively studied as a general informative model for
viral carcinogenesis; however, to date, none of its products have been shown to contain structural or
functional similarities to other oncogenic viruses beyond the primate T-cell lymphotropic virus (PTLV)
family. My laboratory has identified a core structural domain within the HTLV-1 p30II protein with
homology to the E6 oncoproteins of high-risk subtype human papillomaviruses (hrHPVs). Both HTLV-1
p30II and HPV E6 cooperate with the cellular oncoprotein, c-Myc, and prevent p53-dependent apoptosis
by inhibiting TIP60-mediated acetylation of the p53 protein on lysine residue K120. Intriguingly, p53 is
rarely mutated in HTLV-1+ ATLL and HPV+ cervical cancer clinical isolates –although E6 degrades the
p53 protein and significantly reduces its expression through interactions with the ubiquitin ligase, E6AP.
Our preliminary studies have demonstrated that the HTLV-1 p30II and HPV16/18 E6 viral oncoproteins
induce the expression and mitochondrial localization of the TP53-induced glycolysis and apoptosis
regulator (TIGAR) and p53-inducible ribonucleotide reductase (p53R2). Primary patient-derived ATLL
and HPV+ cervical carcinoma samples contain elevated levels of TIGAR and p53R2 that correlate with
oncogenic c-Myc expression. We have further shown that lentiviral-siRNA-knockdown of TIGAR inhibits
in vivo tumorigenesis and metastatic disease progression in xenograft models of HTLV-1-induced T-cell
lymphoma and HPV-induced squamous cell carcinoma. Based upon these findings, we hypothesize that
the unrelated HTLV-1 and high-risk subtype HPVs may have evolved similar strategies to deregulate
host oncogenic and pro-survival signaling pathways by targeting p53 functions. The following Specific
Aims are proposed for this R15 AREA project: 1) to elucidate the molecular mechanisms by which the
HTLV-1 p30II and high-risk HPV E6 oncoproteins modulate p53-regulated pro-survival signals, 2) to
determine how TIGAR and p53R2 contribute to the cooperation between HTLV-1 p30II or hrHPV E6
oncoproteins and cellular oncogenes, and 3) to elucidate the roles of these p53-regulated pro-survival
signals in HTLV-1 and HPV-induced tumorigenesis in vivo. The proposed studies will yield valuable new
insight into the evolutionary relationship between HTLV-1 and other cancer-inducing viruses and advance
our understanding of the roles of p53-regulated pro-survival signals in viral carcinogenesis.

Public health relevance
It is estimated nearly 15-20% of cancers are caused by viral infections, yet the myriad mechanisms by which oncogenic viruses deregulate host cellular growth/proliferative pathways remain to be fully defined. The proposed studies will advance our understanding of how transforming viruses cooperate with cellular oncogenes to cause human cancers and promote neoplastic disease progression. This R15 AREA project could help to identify new anticancer therapeutic targets and will provide excellent research training opportunities for undergraduates and graduate students in the basic oncological sciences.